The Molecular Drivers and Therapeutic Susceptibilities in Lineage State Transitions of Metastatic Prostate Cancer

OVERALL PROGRAM PROJECT SUMMARY/ABSTRACT
The last decade has seen a significant increase in the number of FDA approved treatments for men with
metastatic castrate resistant prostate cancer (mCRPC). Despite these advances, median survival for men with
mCRPC remains less than two years and cross-resistance to therapies within the same class (e.g. Enzalutamide
and Abiraterone) occurs in >95% of patients. Molecular analysis of tissue biopsies has the development of
phenotypic alterations indicative of neuroendocrine prostate cancer (NEPC). These observations gave rise to
the concept of “Lineage Plasticity” wherein PC, under the selective pressure of ARPIs, can undergo lineage
transitions to developmental cellular prostate subtypes as a driver of resistance. However, many patients retain
androgen receptor positive prostate cancer (ARPC) or even the absence of either histologic subtype (Double-
negative prostate cancer or DNPC). Genomic mutations in p53 and RB associate with lineage plasticity, as well
as PC invasion of different metastatic niches, such as liver and bone. However, these alterations are not
exclusive to NEPC and do not explain the molecular triggers of lineage transitions. New technological innovations
and biologic discoveries in our respective laboratories strongly support the overarching hypothesis that early
molecular events promote lineage transitions in metastatic niches that culminate in lethal tumor phenotypes and
offer new opportunities for diagnostic and therapeutic intervention. To address this hypothesis, project aims are:
Project 1: Lineage Addiction in Prostate Cancer: Molecular Interactions and Translational Biomarkers.
This project will study the luminal CRPC state that retains androgen dependence but is resistant to ARPIs. They
will evaluate how the AR transcriptional state is regulated in distinct tumor niches, with AR mutations alone or in
combination with other high-risk mutations, to promote treatment resistance. They will explore new therapeutic
sensitivities and treatment combinations across distinct niches and translational biomarkers in clinical studies.
Project 2: Molecular Transitions Driving AR Loss in Double Negative Prostate Cancer. This project
evaluates the genetic and epigenetic alterations that lead to the DNPC lineage that is independent of androgen
signaling for proliferation and invasion. They will explore why the liver metastatic niche is enriched for this unique
lineage and identify biomarkers that will be studied in two prospective clinical studies.
Project 3. Molecular Drivers and Therapeutic Susceptibilities in Neuroendocrine Prostate Cancer. This
project builds on data from the investigative team on the terminal NEPC differentiation state that drives a rapidly
proliferative disease that responds only to chemotherapy. Using perturb-seq CRISPR screens for high-risk
genomic mutations, they will uncover the drivers of neuroendocrine transformation and biomarkers that will be
evaluated in samples from multiple randomized clinical trials.

Public health relevance
OVERALL PROGRAM PROJECT NARRATIVE Despite new therapeutic advances in metastatic castrations resistant prostate cancer (mCRPC), median OS for men remains less than two years and cross-resistance to therapies within the same class occurs in >95% of patients due to genomic/epigenomic changes and the emergence of lineage plasticity and androgen independence. This proposal seeks to develop a new molecular understanding of lineage addiction and lineage plasticity would tailor risk stratification, treatment monitoring and guide lineage specific therapeutic interventions that will improve outcome for mCRPC. Success in these endeavors will lead to translational biomarkers to predict and monitor for lineage transitions as well as identify new therapeutic targets for resistant prostate cancer.